CVM VetLIRN Veterinary Dagnostic Laboratory Program (U18)

Project Summary Abstract
The Louisiana Animal Disease Diagnostic Laboratory (LADDL) is an accredited
laboratory with the American Association of Veterinary Laboratory Diagnosticians
(AAVLD). LADDL is committed to maintaining the highest accreditation standards,
improving existing diagnostic services, and developing new tests to meet the demands
of its industry stakeholders and regulatory agencies. LADDL works through multiple
state and national cooperative agreements to perform diagnostic surveillance for
endemic, targeted, and foreign animal disease to enhance the biosecurity of the food
and agricultural industries throughout the nation. LADDL is a member of the Veterinary
Laboratory Investigation and Response Network (Vet-LIRN) and will work through this
cooperative agreement to strengthen the network by participating in Vet-LIRN sample
analyses, providing analytical data to support potential regulatory use, and participating
in additional projects as determined by the Vet-LIRN Program Office.

Public health relevance
Project Narrative: Through a collaboration with the FDA’s Veterinary Laboratory Investigation and Response Network (Vet-LIRN), the Louisiana Animal Disease Diagnostic Laboratory will work toward the common mission of promoting human and animal health by expanding our diagnostic capabilities and capacity for routine and emergency response. The continued support of laboratories in this network is crucial for strengthening national food safety by providing rapid detection and response in a large-scale outbreak or emergency event.